Core B: Virology Core

PROJECT SUMMARY – CORE B: VIROLOGY
Zoonotic coronaviruses (CoV) are responsible for three major epidemics/pandemics in the 21st century, including
Severe Acute Respiratory Coronavirus (SARS-CoV) in 2003 and Middle East Respiratory coronavirus (MERS-
CoV) in 2012. In December 2019 a third novel coronavirus designated SARS-CoV-2 emerged in Wuhan China,
and in the space of 18 months has caused over 170 million cases and 3,500,000 deaths in more than 220
countries. About one-sixth of these total cases have been reported in the US, resulting in over 600,000 deaths.
Of concern, multiple distinct SARS-like and MERS-like CoV strains reside in bats and other species and are
poised to emerge in the future, creating a critical need for broadly protective vaccines. We seek to develop a
pan-betacoronavirus vaccine that will universally protect against viruses from the sarbecovirus, merbecovirus,
and embecovirus subgenera. The goals of Core B (Virology, Baric) are to: i) provide group sarbecovirus,
merbecovirus, and embecovirus animal models of human disease for evaluating vaccine performance; ii)
develop reverse genetic platforms, recombinant viruses, and animal models to other high risk zoonotic
coronaviruses; iii) evaluate virus evolution in the expanding SARS-CoV-22 pandemic and create appropriate
reagents to evaluate pan-betacoronavirus vaccine performance in vivo; and iv) evaluate the mechanisms
regulating protective or pathogenic immune responses after homologous (i.e., vaccine-strain) and heterologous
challenge. The overall goal is to identify high-performance pan-sarbecovirus and pan-betacoronavirus vaccine
candidates that provide robust protective immune responses in at least two animal models.